The role of GPI-anchor biosynthesis in sleep regulation

PROJECT SUMMARY
Sleep disorders such as insomnia are common and have major public health consequences. Enormous
resources have been invested in human sleep genomics, with data from several million individuals yielding
genome-wide association study (GWAS) loci associated with sleep disorders. However, these associated
genetic variants principally reside in non-coding regions of the genome and rarely pinpoint the precise location
of the actual effector genes. Mounting evidence suggests that simply attributing GWAS signals to the genes
within the closest genomic proximity is insufficient to identify the genetic variation associated with phenotypic
changes. As such, GWAS results alone are limited to signal discovery, with only indirect implications for
functional gene discovery. Here, we seek to address major barriers to further understanding sleep GWAS
signals by applying genomic, computational, and behavioral approaches to study the basis of human sleep.
We have developed a pipeline for functionally validating sleep genes from human GWAS, and used this to
identify GPI-anchor biosynthesis as a critical regulator of sleep in animal models, as well as humans. In this
application we will identify targets of this pathway in fruit flies, and the underlying mechanism of their impact on
sleep centers in the brain. We will use then apply variant-to-gene mapping in human progenitor cells (NPCs) to
identify how genetic variation associated with sleep-regulating genes impact their function. We will also
characterize the impact of variation in insomnia risk genes by conducting in-depth human phenotyping of
individuals harboring rare variants with predicted loss of function. Our global hypothesis is that genetic
variation in the GPI-anchor biosynthesis pathway, and genes encoding for GPI-anchor proteins are critical
regulators of sleep. Our cutting-edge molecular genomic approaches will elucidate the causal variants and the
corresponding effector genes at these loci.

Public health relevance
PROJECT NARRATIVE: Sleep plays a critical role in the maintenance of physical and mental health, with disturbances in these domains (i.e. insomnia) associated with major public health consequences. Leveraging a combination of genetic, functional and animal model approaches, we aim to characterize the genomic underpinnings of insomnia. This study will fill a critical need to uncover their biologic mechanisms underlying insomnia in order to improve diagnostic, preventive and treatment approaches.